Admin Core Interdepartmental Neuroscience Center

Administrative Organization. There will be three levels of oversight, including: the PSO Directors and Core Directors/Co-Directors to monitor ongoing activities and to interface with users; a Steering committee to review operating procedures and activity reports on an annual basis, as well as to advise on prioritization issues and core effectiveness; and an Advisory Board to offer advice on technology updates and management issues. This organizational structure will be logistically supported by an Administrative Core with a dedicated senior grants manager to assure compliance at all levels. Collectively, this administrative organization will be responsible for ensuring adherence to NINDS Program guidelines; implementing a fair and equitable Core utilization plan; monitoring Core functions, performance, accessibility and user satisfaction; implementing upgrades; securing institutional support and maintaining effective financial administration.